Age and sex differences in the immune response to synthetic materials

Project Summary
The WHO estimates that 1 in 6 people will be 60 years or older by 2030. A hallmark of aging
is the immunological changes that increase susceptibility of this population to inflammatory agerelated
diseases, hinder response to infections and vaccines, and lower regenerative capacity.
Synthetic biomaterials are used in multiple ways including drug delivery, vaccines, prosthetics,
and scaffolds in tissue engineering to promote tissue regeneration. Implanting a biomaterial
creates an injury and initiates the immune-driven development of a foreign body reaction.
Immune-tissue engineering solutions must be designed to modulate the local microenvironment
while overcoming the FBR. With an aging population there is a critical need to understand the
age-specific immune-material interactions to rationally design biomaterial solutions for tissue
engineering. The goal is to identify key material design criteria that effectively modulate aged
immune cells. The overarching hypothesis is that the aged immune dysregulation towards an
effector state compounds the adverse reaction to synthetic materials and prevents scaffolds
from functioning as designed. My proposed research for the R00 focuses on designing materials
for the aged immune system to reduce fibrosis and promote tissue regeneration. The goal of the
R00 is split into 3 aims to understand how we can optimally design materials to promote a
desired immune response in aged cells accounting for biologic sex targeting the innate (Aim 1)
and adaptive (Aim 2) immune system and how both arms of the immune system (Aim 3) can be
used to promote regeneration.

Public health relevance
Project Narrative There is an increasing aging population that relies on biomaterial implants to improve longevity and quality of life. As we age there are fundamental changes in the immune system that impact the ability for tissue to heal as well as the response to biomaterial implant itself. This project seeks to understand how the biologic age and sex of cells alter immune-biomaterial interactions to provide alternative biomaterial strategies for modulating an aging immune system.